STRUCTURE OF HIV TAR RNA VARIANTS W/ ALTERED BASE TRIPLES

In the structure of HIV TAR RNA, there is a base triple formed between an A-U base paii in the upper stem of TAR and a U residue in the bulge. However, we do not observe the imino proton consistent with this triple. In order to separate the contributions to the RNA structure from the WatsonCrick AU base pair in the triple from the Hoogsteen A-U base pair, we are examining the structure of two TAR variants. In the first variant, the A-U base pair is replaced with an A-C base pair, while in the second, the U in the A-U pair is deleted, and the Hoogsteen A-U pair is replaced by a C-G Hoogsteen pair. In addition, two synthetic base analogs are being incorporated into the TAR bulge. We have successfully incorporated dihydro-uridine by in vitro transcription into TAR, which provides an imino proton stable to exchange at the position of the putative base triple. Through a collaboration with Prof. Larry McLaughlin at BC, we will incorporate a C-nucleoside that has a non-exchangeable proton at the C2 position, which should provide several additional key NOEs to define the base triple geometry. For both of these variants, a system was developed where the TAR hairpin was divided into two separate strands. The wild type sequence and a deoxythymidine residue have been incorporated successfully, and this bipartite system forms the correct structure in the presence of argininamide.